11 Solid Tumor Therapeutics Program

SOLID TUMOR THERAPEUTICS PROGRAM (STTP): PROJECT SUMMARY
The Solid Tumor Therapeutics Program (STTP) is focused on discovering somatic and germline
genomic alterations that are either shared or unique across various solid tumor malignancies, and
translating these discoveries into novel therapeutics that will improve the quality of life and
survival for cancer patients. Two fundamental thematic areas (Genomics Technologies and
Discovery, and Developmental Therapeutics [DT]) were organized to promote disease-specific
studies in neuro, head and neck, thoracic, gastrointestinal, genitourinary, and gynecologic
oncology. The STTP is coordinated through a leadership committee, research meetings,
seminars, retreats, and other educational activities. Training for junior investigators is
implemented through a mentorship plan and is supported through NCI-funded T32 (HD007499),
K12 (CA167540), and Clinical and Translational Scientific Award (CTSA) educational programs.
We identified areas of institutional strength and developed three research aims for the next
project period. Aim 1. Develop innovative therapeutic strategies by identifying genomic,
epigenomic, proteomic, and metabolomic (‘omic) alterations that occur in solid tumors and by
mapping their spatiotemporal evolution using preclinical models and tumor specimens. Aim 2.
Determine how genomic alterations interact with immune landscapes in solid tumor malignancies;
identifying these potential synergies will improve therapeutic outcomes. Aim 3. Explore the
relationships among germline variants and their effects on cancer susceptibility and treatment in
solid tumor malignancies, and evaluate effects on cancer biology. These aims are designed to
elucidate the effects of genetic instabilities, DNA repair defects, and specific inhibitors on solid
tumor initiation, maintenance, progression, and chemoresistance. The STTP leadership facilitates
and encourages collaborative interactions between disease-specific investigators and
translational experts to promote translational and clinical research. These interactions are
achieved through working-group meetings, focus-group meetings, seminars, and funded
programs such as the NCI U54 CA224083 PDX clinical trial network and the NCI U2C CA233303
Washington University Human Tumor Atlas Research Center, which will construct detailed 4D
atlases for breast cancer, glioblastoma, and pancreatic adenocarcinoma. The STTP has 47
members from 13 departments at Washington University School of Medicine. The STTP is
supported by a total of $25.9 million direct costs in cancer-related funding, $5.8 million in NCI
funding, and $5.8 million in other peer-reviewed funding. STTP members published 1,723 papers
during 2014–2018, with 33% resulting from inter-programmatic collaborations and 24% resulting
from intra-programmatic collaborations. During 2014–2018, STTP members participated in 1,511
clinical trials, 56% of which were interventional trials. These trials enrolled 32,867 patients, with
6,274 enrolled in interventional trials, 4,597 in interventional treatment trials, 1,354 in institutional
interventional treatment trials, and 1,274 in early phase or first-in-human interventional treatment
trials.